Photothermal Mid-Infrared Single Molecule Super-Localization Microscopy

Summary
Lipid nanoparticle (LNP)-based formulations are widely used for delivering macromolecular therapeutics,
including mRNA. Biologics account for ~55-60% of the total current pharmaceutical product market, with all
trends pointing to continued increases in market share. However, transfection efficiency of mRNA is severely
hindered by various loss mechanisms, including rapid clearance, suboptimal cellular uptake, and incomplete
endosomal escape. These processes reduce the effective delivery of mRNA to only a small fraction (~1-2%) of
the administered dose. As a consequence, comparatively subtle patient-to-patient differences in loss can
translate to large variability in therapeutic dosing, with corresponding variability in efficacy and side-effects. To
improve transfection yields and better understand the intracellular barriers to mRNA delivery, particularly
during the key step of endosomal escape, there is a pressing need for new tools capable of providing
chemically selective, nanoscale insights in the intracellular fates of LNPs and their cargos within live cells.
The goal of this project is to develop fluorescence-detected photothermal infrared (F-PTIR) microscopy to
track the intracellular processes governing mRNA release from LNPs in real-time and with ultra-high spatial
resolution, well below the optical diffraction limit. In brief, fluorescence from labelled mRNA will serve as a local
temperature sensor. Upon IR absorption from the surrounding medium, local transient temperature increases
result in corresponding reductions in fluorescence quantum yield. Change in fluorescence intensity as the IR
wavelength is tuned enables IR absorption spectroscopy with a spatial resolution set by fluorescence imaging
and heat transfer. Embedding fluorescently labeled mRNA within deuterated LNPs will yield IR spectra
dominated by the CD stretching modes of isolated LNPs. Endosomal uptake will be tracked both by the
physical position of fluorescence within single cells and by the changes in the lipid vibrational spectra (e.g.,
addition of CH-stretching modes from native lipids in endosome membranes). Tight timing control in
combination with heat-transport modeling will be used to quantify distances between the fluorescence reporter
and different IR absorbers. The relatively rare subset of internalized LNPs capable of releasing cargo intact
into the cytosol will be identified by their corresponding change in local microenvironment (e.g., loss of CD
stretches for mRNA solubilized within the cytosol) together with their 3D position and mobility measured by
single molecule localization microscopy (SMLM). Once developed and validated, the proposed instrumentation
can support informed optimization of therapeutic nanoparticle formulations designed to promote dosing yield
and therapeutic efficacy.

Public health relevance
Title: Photothermal Mid-Infrared Single Molecule Super-Localization Microscopy Project Narrative Emerging lipid nanoparticles (LNPs) have advanced the delivery of otherwise intractable therapeutic macromolecules. However, critical gaps remain in understanding how these nanoparticles facilitate intracellular uptake and release of their cargo. This project aims to develop advanced vibrational spectroscopic probes that will allow us to selectively track and detect the release of therapeutic mRNA from LNPs in live cells, improving our ability to study and optimize nanoparticle-based drug delivery systems.